Dietary Ketone Supplementation as a Novel Strategy to Attenuate the Adverse Vascular and Renal Consequences of High Dietary Salt in Older Adults

PROJECT SUMMARY
Excess dietary salt is associated with increased risk for hypertension and cardiovascular disease (CVD), the
leading cause of death in the United States. High dietary salt is also associated with increased chronic kidney
disease (CKD) risk, another leading cause of morbidity and mortality. Yet, 90% of adults consume excess dietary
salt based on the Dietary Guidelines for Americans recommendation. Americans struggle to reduce their salt
intake because the vast majority (~70%) of dietary salt comes from processed foods and meals prepared at
restaurants, making it difficult to alter their dietary salt. As a result, there have been calls for alternative strategies
to counteract excess consumption of dietary salt. We have identified Beta-hydroxybutyrate (β-OHB) as a
promising tool to counteract the adverse cardiorenal health effects of high dietary salt. β-OHB is a ketone body
typically produced during prolonged exercise, fasting, and ketogenic dieting. Alternatively, oral ketone
monoesters are a type of ketone supplement that are metabolized into β-OHB. While most individuals are unable
to adhere to strict ketogenic diets, oral ketone supplements are convenient, typically well tolerated, and increase
β-OHB to a similar or greater extent. Recent rat data suggests that high dietary salt suppresses β-OHB
production and that increasing β-OHB via ketone supplementation counteracts the adverse effects of high salt
on cardiorenal function. Similar to the published rodent data, our pilot data also indicate that high dietary salt
reduces fasting plasma β-OHB in humans. Recently published data also demonstrate that increasing β-OHB
with ketone supplementation can improve blood pressure and vascular function in humans under certain
contexts. However, it is unclear whether raising β-OHB via ketone supplementation can protect older humans
against the adverse cardiorenal effects of high dietary salt. Therefore, we are proposing to examine whether
taking a ketone monoester supplement concurrently with high salt for 10 days counteracts the adverse effects
of short-term high dietary salt on blood pressure (Aim 1), vascular function (Aim 2), and kidney injury and blood
flow (Aim 3). We will utilize a double masked, randomized, placebo-controlled crossover design pilot trial in 30
older adults who will also undergo a low salt control intervention and high salt alone. The PI (Dr. Austin Robinson)
has a strong record of productivity investigating the cardiorenal consequences of short-term high dietary salt and
has assembled an outstanding interdisciplinary team of co-investigators and consultants to help secure future
R01 funding for this line of research. The public health impact of this innovative project is that establishing
strategies (e.g., ketone supplementation) to attenuate the adverse cardiorenal effects of high dietary salt could
lead to reductions in CVD and CKD risk and mortality.

Public health relevance
PROJECT NARRATIVE High dietary salt intake is a well-established risk factor for high blood pressure, cardiovascular disease (CVD) and chronic kidney disease (CKD), yet ~90% of Americans consume excess dietary salt based on the recommendations set by the Dietary Guidelines for Americans and the American Heart Association. The established link between dietary salt with CVD and CKD, particularly in older adults, highlights a critical biomedical research need for strategies to counteract the adverse cardiorenal consequences of high dietary salt; and we have identified beta-hydroxybutyrate, a liver-derived ketone body, as a potential target to counteract the adverse cardiorenal effects high dietary salt. Using a randomized placebo-controlled crossover design study, we will test the hypothesis that concurrently giving a ketone monoester supplement (exogenous source of beta- hydroxybutyrate) with high dietary salt (10 days) will attenuate the effects of short-term high dietary salt on cardiorenal health (blood pressure, peripheral vascular function, kidney injury biomarkers, and kidney blood flow) in older adults.